CTSA Institutional Mentored Career Development Program (KL2)

PROJECT SUMMARY
At the core of developing a thriving national translational research enterprise is the need to develop the next
generations of researchers skilled in the techniques and culture of translational research, able to collaborate
within teams and across disciplines. The established Tufts CTSI KL2 program has demonstrated success in
training junior faculty who remain engaged in their careers in translational research aimed at improving health.
Building on our success, we will expand upon our training through the following aims: KL2 AIM 1: Recruit,
select, and train a diverse group of junior faculty who demonstrate interest and promise in translational
research across the entire T1-T4 spectrum, deploying five KL2 positions that will leverage the partnerships
across Tufts CTSI; KL2 AIM 2: Provide broad translational research training that imparts the skills needed for
a sustained career in translational science. This will include exceptional training that includes formal didactic
training, multi-disciplinary team mentoring, and support through the Junior Faculty Research Career
Development Forum and Tufts CTSI resources; KL2 AIM 3: Expand career development opportunities by
adding studio and practica experiential learning to enhance translational research training in: a) Team science;
b) Stakeholder engagement; c) Clinical trial innovation; d) Research process improvement; and e) Drug and
device development/regulatory processes.
The outcome of our training will be a group of translational investigators across multiple disciplines within Tufts
CTSI who are highly skilled in broadly engaged team approaches. These are the investigators needed to
advance interdisciplinary translational research that will address the complex challenges to improving health.